Investigation of Synthetic Cannabinoid Exposures and Pharmacological Consequences

PROJECT SUMMARY
Synthetic cannabinoids (SC) produce psychological effects resembling those of 9-tetrahydrocannabinol (THC)
but are usually more potent and efficacious. Notably, the use of these substance is often associated with greater
toxicity. Clusters of severe adverse reactions and death have been reported internationally, including in the U.S.
and New Zealand. The global nature of SC abuse argues for an international approach to addressing the
problem. To this end, one overall goal of this project is to strengthen a nascent international collaboration
initiated among laboratories in the U.S. (RTI International) and New Zealand (University of Otago). Through this
collaborative and multi-disciplinary effort, we will determine molecular and pharmacokinetic mechanisms that
may underlie differences in the in vivo effects of chemically diverse SC related to their abuse potential and to
their toxicological effects in peripheral systems. A foundational hypothesis for this proposed work is that the both
the behavioral effects and the toxicological effects associated with SC use are related to their differential
interactions with the endogenous cannabinoid system, as compared to THC and other partial CB1 receptor
agonists. This hypothesis will be evaluated through systematic study of the SAR of SC and the mechanisms
underlying their central and peripheral actions (i.e., their molecular fingerprints). This work will enhance ability
to predict which new compounds are likely to have toxicological effects when – or before – they appear and will
provide a scientific basis for evaluation of potential health concerns associated with use of these compounds.
This research also will increase knowledge of the structure-activity relationships at cannabinoid receptors,
resulting in deepened understanding of endocannabinoid system functioning.

Public health relevance
PROJECT NARRATIVE Synthetic cannabinoids produce psychological effects resembling those of 9-tetrahydrocannabinol (THC) but are usually more potent. In the last decade, over 300 synthetic cannabinoids have been identified by government agencies in more than 100 countries, currently accounting for 29% of new psychoactive substances (NPS). Further, as the structures of these illicit chemicals have evolved to avoid forensic detection, they have become associated with greater toxicity. The overall goal of this project is to determine biological and behavioral mechanisms underlying the toxic and addictive potential of emerging synthetic cannabinoids. In addition to addressing a significant public health issue, the proposed research also has substantial potential to provide insight into the functioning of cannabinoid receptors, an integral component of the endocannabinoid system.